Project-004

Respiratory infection with COVID-19 (the SARS-CoV-2 virus) has become pandemic. It has significant mortality and high morbidity, particularly among older patients. Death typically results from severe respiratory infection leading to ARDS. To bind to cell membranes, SARS-CoV-2 requires S protein cleavage either by the transmembrane serine protease, serine 2 (TMPRSS2), or by the cathepsin B and L (CatB/L) endosomal complex. TMPRSS2 can be inhibited by camostat methylate (CM), but CM is an irritant and may not be ideal for airway administration in patients with evolving ARDS. Of note, CatB/L is inhibited by endosomal alkalinization using ammonium chloride. As part of P01 project HL128192, we are studying the beneficial effects of airway alkalinization in patients with asthma and cystic fibrosis. We have a drug, alkaline glycine buffer (AGB), that is being produced for inhalation in our P01 project. This drug has an active IND and has excellent safety data. We therefore tested to determine whether AGB would cause intracellular alkalinization in cultured primary human airway epithelial cells obtained from our P01 subjects. It did; and the drug was well-tolerated by the cells in vitro (as it is in vivo). The next step is to determine whether AGB inhibits viral replication (plaque formation as a function of multiplicity of infection [MOI]) and viral entry (PCR) in our primary human airway epithelial cultures. To do this, we are partnering with our Indiana University BSL3 virology lab (Dr.?s Gilk and Robinson) who anticipate delivery of SARS-CoV-2 next week. Their lab has completed preparation, particularly in anticipation of this project. If in fact AGB inhibits viral replication, we would propose to discuss with the FDA the possibility that we could expand our IND, allowing a trial in patients at risk for respiratory distress associated with known COVID-2 respiratory disease. Ultimately, outcomes of this trial would be proposed to include: mortality (primary); as well as ICU length of stay and oxygen saturation index area under the curve (secondary). In the study proposed here, we plan to accomplish three Aims. First we will test the hypothesis that SARS-CoV-2 S-protein cleavage is inhibited by human primary airway epithelial cell alkalinization using AGB. Second, we will test the hypothesis that AGB exposure prevents SARS-CoV-2 replication and cell entry in primary human airway epithelial cells in vitro. Third, we will perform dose-response and time course experiments to determine whether the inhibition of SARS-CoV-2 replication and cell entry using AGB could be a realistic therapy.

Public health relevance
Overall Narrative Our overall goal is to translate new, small molecule drugs into personalized therapies for severe asthma and cystic fibrosis (CF). Severe asthma and CF are disabling obstructive lung diseases that have been a particular focus of our therapeutic development efforts. In our pediatric and internal medicine research programs, we have developed potentially effective small molecule therapies for both. In many cases, these therapies are similar or identical in both diseases. For example, S-nitrosoglutathione (GSNO), GSNO-mimetic compounds and GSNO reductase inhibitors are potentially active in both conditions. However, it is now clear from our work and that of others that there is substantial clinical heterogeneity in both severe asthma and CF, and that there are specific patients who will and will not respond to each treatment. As with most drugs, patients who are non-responders could actually be harmed by unnecessary treatment. We have now developed noninvasive or minimally invasive biomarker approaches to identify responders and non-responders to specific treatments. Therefore, we propose in the first phase of this program to use these novel techniques to identify patients who will and will not likely respond to our proposed therapies. We will study targets and mechanisms of action for these therapies, including biochemical and epigenetic effects. We will also use these data to inform studies of interactions between therapies in vitro and in vivo. In the second cycle, we will begin personalized clinical trials using specific clinical testing and selection criteria developed in the first cycle. Many severe asthma and CF patients are benefitting already from personalized biological and small molecule therapies that have recently been developed; our proposed program is meant to complement these novel therapies in order to optimize the ease and efficacy – and minimize the cost - of treatment for each patient. Our multidisciplinary program is based strengths in drug development, clinical drug trials, airway redox chemistry, cell culture, cell physiology and genetics as they relate both to severe asthma and to CF.